Admin-Core-001

Administrative Core
Abstract
We have established a centralized administrative system for this this large multi-project and multi-center proposal
to monitor and manage progress, provide documentation and report, perform internal and external
communication and importantly enhancing synergies among the components of the project and with external
partners. The Administrative Core (1) will centralize all the practical matters. This will be done by an experienced
Project Manager in conjunction with the Multi-Investigators in support of the scientific goals of Projects 1, 2 and
3 and of the Clinical (2), Data Management and Analysis (3), and Service (4) Cores. The Administrative Core
will facilitate exchange of information, tools, and approaches among between the projects and the cores. It will
serve as the main communication and integration hub within the structural organization of the overall project for
the non-scientific operational aspects of this research consortium and as a conduit for internal and external
consideration of the scientific components that emerge from research projects. The Administrative Core Project
Manager will work under the direct supervision of the communicating PI with the guidance of the Multi-PIs and
in consultation with the Scientific Leadership team. The project manager will act as a liaison for the projects and
cores to ensure smooth operations and overall efficiency and will aid with managing budgets, planning
discussions and meetings, arranging travel and communications for project and core PIs, SLT, ESAC, HIPC and
NIH officials.